Temperodynamic neural variability as an early-emerging biomarker of autism spectrum disorders

Project Summary
Current gold-standard diagnostic techniques for Autism Spectrum Disorder (ASD) rely on behavioral
observation, and diagnosis is often not conferred until after age 4. This delay is unfortunate, because early
intervention can drastically improve outcomes. Given the rapid and sweeping changes in neural architecture,
cognitive ability, and behavioral repertoire that occur within the first year of life, identifying early-emerging
neurobiological markers that can predict abnormal neurodevelopment before behavioral symptoms manifest is
a public health priority. Following the onset of behavioral signs and symptoms, there is great need for stratification
biomarkers that can dissect ASD heterogeneity, thereby informing individualized treatment plans. Such a
precision-medicine approach necessitates greater understanding of the longitudinal pathways of development
in domains. This will set the stage for biomarkers that are sensitive to, and predictive of, changes in behavior
resulting from effective interventions.
This proposal aims to identify and validate features of temperodynamic brain signal variability that can serve
as diagnostic, risk, and/or treatment response biomarkers of social dysfunction in ASD. Traditionally modeled
out of analyses as mere “noise”, measures of temperodynamic neural variability capture the inherently fluctuating
nature of the brain, which is increasingly understood to play a valuable functional role in the establishment of
neural networks and in the transfer of information throughout the brain. Temperodynamic neural variability has
been linked to cognitive performance, development, and autism.
The current proposal will capitalize and expand upon this promising neurobiological marker to 1) identify and
optimize metrics for assessing temperodynamic neural variability by conducting the most comprehensive
comparison of time-series analytics of any study to date, and 2) establish these metrics as biomarkers for
neurodevelopmental outcomes by leveraging large clinical and longitudinal data sets consisting of multilevel
genetic, neural, and behavioral data.
The proposed research extends the candidate’s prior work through new training in autism research,
translational developmental cognitive neuroscience, and timeseries and predictive analytics applied to large-
scale datasets necessary to advance biomarker development. These training goals will support the candidate’s
ultimate career goal of developing an independent research program dedicated to the use of interdisciplinary,
multidimensional, collaborative, and cutting-edge approaches to understanding the neurobiological and
developmental factors that contribute to individual differences in social behavior across the full continuum of
abilities – from healthy to disordered. The University of Virginia is committed to high caliber, collaborative
research and scientific preeminence in neuroscience, autism, and data science and will provide the ideal
environment for conducting this type of interdisciplinary, multidimensional child health-oriented project.

Public health relevance
Project Narrative Current gold-standard diagnostic techniques for Autism Spectrum Disorder rely on behavioral observation, and diagnosis is often not conferred until after age 4. This delay is unfortunate, because early intervention can drastically improve outcomes. This proposal seeks to identify and validate early-emerging neurobiological markers of ASD that occur before behavioral symptoms manifest to serve as diagnostic, risk, and/or treatment response biomarkers of social dysfunction in ASD.